Discipline D: Special Project - Analytical Track 1: Sample Collection

Hawaii State Department of Health State Laboratories Division Laboratory Preparedness and Response Branch Biological Response Section Discipline D ? Analytical Track 1: Sample Collection